Elucidating the functional mechanism of NLRP3 inflammasome activation

Innate immunity is an absolutely essential host defense mechanism that, if perturbed, can itself
cause a large number of human diseases. Among innate immune defense mechanisms,
inflammasomes are cytosolic supramolecular complexes that recruit and activate inflammatory
caspases, in particular caspase-1, to mediate proteolytic maturation of proinflammatory cytokines
in the IL-1 family, and induce the rapid inflammatory form of cell death known as pyroptosis.
Cytokine release and pyroptosis both signal danger to the rest of the immune system and
pyroptosis kills infected or damaged cells to curtail the spread of the disease.
NLRP3 is the inflammasome sensor that has caught the attention of the field and is emerging
to be a general sensor of membrane damage and cellular stress, induced by pathogens and
endogenous danger signals such as bacterial toxin nigericin, extracellular ATP, uric acid crystals,
cholesterol crystals, hyaluronan and amyloid-β fibrils. Uric acid crystal-induced inflammasome
activation is causal to severe joint inflammation in gout, and other stimuli could contribute to
cardiovascular and neurodegenerative diseases. NLRP3 has a tripartite organization with an N-
terminal effector domain known as PYD, a central nucleotide-binding ATPase domain (NBD, also
known as NACHT) and a C-terminal LRR domain. Upon activation, NLRP3 recruits the adaptor
ASC through PYD-PYD interactions and ASC further recruits caspase-1 through CARD-CARD
interactions to induce proximity-promoted caspase dimerization and activation.
Despite the great academic and clinical interest on NLRP3, the molecular pathway and
mechanism for NLRP3 activation remain unclear, likely due to the complicated conformational
transitions and intracellular trafficking that are just beginning to be elucidated. In this application,
we propose to elucidate the functional mechanism of NLRP3 inflammasome activation by
investigating the conformational transitions and intracellular trafficking.

Public health relevance
The NLRP3 inflammasome forms a supramolecular complex that recruits and activates caspase-1, and plays key roles in innate immune surveillance of infections and other types of danger. These important functions of NLRP3 have garnered extensive interest by both academia and industry, which has transformed NLRP3 as a heavily pursued therapeutic target for diseases of aging and inflammation, including cardiovascular and neurodegenerative diseases. Investigating the functional mechanism of NLRP3 inflammasome activation would provide mechanistic insights that guide the development of NLRP3-targeted therapies.